2/2 Treating Mothers with ADHD and their Young Children Via Telehealth: A Hybrid Type I Effectiveness-Implementation Trial

Parental ADHD, present in 25-50% of families of children with ADHD and frequently untreated,
interferes with effective parenting and predicts poor child developmental and behavioral
treatment outcomes. Based on the literature and our own pilot data, we are randomly assigning
parents with ADHD and their young at-risk children to one of two conditions: (1) stimulant
medication for parents with ADHD followed by a child treatment strategy (CTS) beginning with
behavioral parent training (BPT) with the added recommendation of child stimulant
treatment if the child remains impaired or (2) a CTS without treatment for maternal ADHD on
parent, child, and family outcomes. In line with the NIMH Strategic Framework for Addressing
Youth Mental Health Disparities, the parent grant, a hybrid effectiveness-implementation trial
comparing two intervention approaches for families in which a parent and child has ADHD,
focuses on screening and family-based intervention in low-resource pediatric primary care
settings and includes an existing mentoring component. This Administrative Supplement to
Recognize Excellence in Diversity, Equity, Inclusion, and Accessibility Mentorship proposal is
intended to expand the proposed research within the scope of the parent grant, while providing
deeper independent research opportunities for members of our research team who meet NIH
diversity criteria. Aims are: (1) To understand lived experiences of low-resource families in
which the parent and child have ADHD; (2) To understand parent preferences for the different
parenting skills/intervention modules; and (3) To explore predictors of treatment engagement in
our sample.

Public health relevance
In line with the NIMH Strategic Framework for Addressing Youth Mental Health Disparities, the parent grant, a hybrid effectiveness-implementation trial comparing two intervention approaches for families in which a parent and child has ADHD, focuses on screening and family-based intervention in low-resource pediatric primary care settings and includes an existing mentoring component. This Administrative Supplement to Recognize Excellence in Diversity, Equity, Inclusion, and Accessibility Mentorship proposal is intended to expand the proposed research within the scope of the parent grant, while providing deeper independent research opportunities for members of our research team who meet NIH diversity criteria. Aims are: (1) To understand lived experiences of low-resource families in which the parent and child have ADHD; (2) To understand parent preferences for the different parenting skills/intervention modules; and (3) To explore predictors of treatment engagement in our sample.